Plasma membrane rupture in alcohol-associated hepatitis

Project Summary
Alcohol-associated hepatitis (AH) is a severe, potentially life-threatening form of alcohol-associated liver
disease (ALD) with limited therapeutic options. Cholestasis and biliary dysfunction are common in AH
patients and can worsen AH prognosis. Plasma membrane integrity usually determines whether a form
of cell death is pro-inflammatory. Lytic cell death pathways can cause plasma membrane changes and
eventually lead to plasma membrane rupture (PMR), which releases intracellular contents that stimulate
the immune response. The role of PMR in ALD remains unknown. There is a critical need to determine
the role of cholestasis in promoting PMR in ALD and the therapeutic potential of targeting PMR in AH.
The long-term goal is to contribute toward the development of clinically useful, mechanism-based
diagnostic and therapeutic interventions to improve outcomes in patients with advanced ALD. The overall
objectives for this proposal are to 1) determine the role of PMR in ALD, and 2) investigate the
mechanism by which cholestasis promotes hepatocellular PMR in the setting of ALD. The central
hypothesis is that cholestasis promotes PMR in hepatocytes, thereby enhancing alcohol-associated liver
damage. The rationale for the proposed research is based on the identification of cholestatic injury in a
preclinical model of AH. The overall objectives of this application will be attained by pursuing two specific
aims: (1) Determine the role of PMR in ALD; (2) Investigate the mechanism by which cholestasis
promotes hepatocellular PMR in ALD. Under the first aim, the working hypothesis will be determined in
mice and in vitro cell or organoid cultures with a key PMR contributor knocked down by vivo-
morpholinos. For the second aim, the working hypothesis will be tested in liver tissues from ALD patients
and in in vitro cell or organoid cultures to understand the role of bile acid-mediated pathways in PMR.
The contribution of this proposal will be to determine the role of PMR during the progression of ALD and
begin to clarify the mechanisms underlying hepatocellular PMR in ALD. Upon completion of the proposed
project, there is the promise that a significant advance in understanding the mechanism of AH will have
been made, and a mechanistic link will have been established between cholestasis and hepatocellular
PMR in ALD. The successful completion of the proposed studies will be significant because they are
expected to offer novel therapeutic targets for ALD.

Public health relevance
Project Narrative Alcohol-associated hepatitis (AH) is a liver condition linked to excessive alcohol consumption, and effective treatments are scarce. This study aims to investigate how cellular membrane damage contributes to AH, offering hope for new treatment approaches. Ultimately, this research seeks to improve the prognosis of AH patients by revealing innovative therapeutic strategies.